Cardiometabolic Consequences And Pathway Of Weight Gain Associated With Dolutegravir-Based Antiretroviral Therapy In Haiti. A Collaborative Study Between GHESKIO And CCASAnet

ABSTRACT
Haiti has the largest number of persons with HIV (PWH) in the Caribbean. PWH have a higher risk of developing
metabolic and cardiovascular disease (CVD), which are leading causes of mortality among Haitians and other
residents of low and middle-income countries (LMICs), driven in part by high rates of hypertension, elevated
fasting plasma glucose and high body mass index. Weight gain is common early after starting antiretroviral
therapy (ART), particularly among PWH on an integrase strand transfer inhibitor (INSTI)-based regimen. The
INSTI-containing combination regimen of tenofovir disoproxil fumarate, lamivudine, and dolutegravir (TLD) is the
most commonly prescribed ART regimen in LMICs, but at present there are few data on the consequences of
weight gain on ART in these settings. Consequently, there is a critical need for innovative approaches to 1)
Determine the features and severity of cardiometabolic disease risk accompanying weight gain among TLD
recipients in LMICs, including insulin sensitivity, blood pressure, lipid profiles and systemic inflammation; and 2)
Determine the metabolic mechanisms underlying weight gain to guide the development and implementation of
effective prevention and treatment strategies.
GHESKIO (Groupe Haitien d’Etude du Sarcome et des Infections Opportunities) is the largest HIV clinic in the
Americas, a founding member of CCASAnet (the Caribbean, Central and South America network for HIV
epidemiology) and has a 37-year track record of NIH research on HIV and associated comorbidities. Building
upon this infrastructure, our multi-disciplinary study will leverage advanced metabolic phenotyping and multiomic
data analysis to elucidate the bioenergetic pathways underlying weight gain on TLD and the cardiometabolic
consequences among PWH in LMIC, where diet and lifestyle factors differ from higher income countries.
Aim 1 will assess whether weight gain on TLD is associated with increased insulin resistance, blood pressure,
dyslipidemia, and inflammation. We will enroll 200 previously ART-naïve patients who initiated TLD at GHESKIO
12 to 24 months previously and gained <3% versus 10% body weight to define the factors associated with
weight gain including sociodemographic variables, appetite, food security and physical activity, and whether
weight gain is associated with higher HOMA-IR, fasting lipids, systolic and diastolic blood pressure, and
inflammatory markers linked to CVD. Aim 2 will determine the metabolic and lipid pathways associated with
weight gain in the first 12 months of TLD exposure using metabolomic and lipidomic profiling. We will enroll 60
ART-naïve patients initiating TLD and perform fasting metabolomic and lipidomic profiling at baseline and 12
months to identify the pre-ART pathways predisposing to weight gain. This project will develop new capacity for
sophisticated cardiometabolic research and analyses at GHESKIO and within CCASAnet more broadly, and the
results of this study will provide preliminary data on whether weight gain on TLD may represent an emerging
threat to health outcomes in the context of the wide implementation of this regimen in LMICs across the world.

Public health relevance
PROJECT NARRATIVE Persons with HIV have a higher risk of developing metabolic and cardiovascular diseases, which are leading causes of mortality among residents of low and middle-income countries (LMICs). Weight gain is common after starting integrase strand transfer inhibitor (INSTI)-based antiretroviral therapy, which is increasingly being used for HIV treatment in LMICs. This study will assess the prevalence of cardiometabolic disease among persons with HIV who gain weight on INSTI-based regimens in LMICs, and the metabolic and lipid pathways contributing to weight gain.